Innovative approaches to measuring and identifying risky sexual behaviors

PROJECT ABSTRACT
Trading sex for compensation (e.g., money, drugs, alcohol) is a complex public health problem. Significant
increases in internet usage have drastically changed the landscape of virtual sex trading (e.g., photos,
webcamming). However, our understanding of sex trading is methodologically limited, as it most often relies on
a single item, e.g., “have you ever traded sex for money or drugs?” Extant research does not differentiate
between sex trading type (e.g., virtual vs. in-person), circumstances (e.g., economic need), compensation type
(e.g., money, substances), risks (e.g., unprotected sex, victimization) and protective factors (e.g., harm
reduction strategies). We have developed a multi-item sex trading measure to identify sex trading behaviors
and their associated compensations, circumstances, risks, and harms. We validated our measure in a sample
of university students, and we found that 11% of undergraduate students and 18.1% of graduate students
reported at least one sex trading behavior, as compared to 2 to 4.5% of students in prior studies. Therefore, in-
person and virtual sex trading may be more widespread and relevant to a larger segment of the population
than previously assumed. Guided by the Risk Amplification and Abatement Model, this novel, multi-phase,
mixed-methods proposal aims to: (1) adapt our validated sex trading measure for the general population; (2)
use the resulting measure to identify the prevalence and associated characteristics (e.g., adverse experiences,
substance use, mental health problems, and violence) of sex trading in a nationally representative sample of
young adults (ages 18-34); and (3) examine the characteristics of sex trading in a non-probability sample of
young people who report having participated in at least one sex trading behavior (ages 18-34). In aim 1, we will
conduct 2-3 waves of cognitive interviews with people with who have traded sex to ensure clarity and
relevance of our measure for a more diverse general population. In aim 2, we will use our resulting measure to
assess sex trading in a nationally representative, probability-based sample (Amerispeak). In addition to
reporting the prevalence of sex trading and associated characteristics (e.g., STIs, substance use), we will use
Latent Class Analysis (LCA) to examine typologies of sex trading based on acts and associations between the
resulting classes and compensation types, circumstances, and consequences. In aim 3, we will use web-
based, Respondent Driven Sampling (webRDS) and replicate aim 2’s LCA to understand differences and
similarities in sex trading among young adults who report sex trading and are at high risk of adverse outcomes.
Data gleaned from these two samples will allow us to understand whether and how circumstances and
associated harms differ between those who are captured in a nationally representative sample and those
targeted based on identified sex trading, thereby ensuring that the experiences of the most vulnerable are
made visible. Findings have the potential to transform our understanding of sex trading, which is needed to
advance interventions and policies to support youth across settings.

Public health relevance
PROJECT NARRATIVE Extant research has predominantly used a single question to assess the complex phenomenon of sex trading, which has grossly limited our understanding of sex trading and its associated risks and protective factors. The proposed study will (1) refine a sex trading questionnaire that we developed and validated for university students who trade sex, (2) identify the prevalence and circumstances of sex trading in a nationally representative sample, and (3) understand the circumstances and conditions under which young people trade sex in a rigorously obtained community sample that includes racial, ethnic, and gender minorities who are often missed by national studies. Findings will result in a comprehensive understanding of sex trading behaviors and consequences in the United States, which is needed to inform prevention and intervention strategies to reduce harm.